Training Program in Immunology

ABSTRACT
The Mayo Clinic Immunology Ph.D. Training Program seeks to train leaders for the next generation of
immunologists. This training grant proposal requests support for 6 pre-doctoral students who will be trained in
a productive biomedical research program supported by a premier academic not-for-profit medical institution.
The highly productive training faculty provide a rich training environment with basic and clinical investigators
combining studies of fundamental immunology with translational potential. The training program has an
exemplary track record in preparing students to succeed in scientific careers. Of all students who have
successfully completed our Ph.D. Training Program , 98.9% have remained in science, science-related fields
or medicine. 54.9% of those graduates currently hold academic rank, a rate almost twice the national average.
Students in the program receive advanced training in primary literature and cutting edge technology focused
coursework and electives in a multidisciplinary setting. Milestones in the program place emphasis on each
trainee mastering the skills needed to formulate critical questions, and devising experimental strategies to
provide definitive insights into the questions being addressed. Students learn to communicate ideas and
research findings effectively using oral and written formats and practice these skills in classroom settings, in
grantsmanship courses, at national and international scientific meetings, and by publishing original research
articles in scientific journals. The typical training period for trainees supported by this grant is 5.2 years, capped
by mentoring for the next phases of their developing careers.

Public health relevance
Project Narrative This training grant supports predoctoral trainees in the Immunology Training Program of Mayo Graduate School, providing students with the requisite research and leadership skills to become heads of research laboratories and leaders in the biomedical sciences. Understanding how the immune system functions and its role in disease pathogenesis is critical to developing novel approaches to cure disease. The young scientists supported by this training grant will become the next generation of innovators to develop new therapies for immune-related disease.